RELMalpha-expressing macrophages mediate host disease tolerance in mucosal infection

The optimal host response to microbial pathogens requires balancing effective pathogen killing
with limiting tissue pathology caused by the pathogen or by the host’s own immune response.
This host disease tolerance phenomenon is especially critical in infections with helminths, which
are macroparasites that can cause severe tissue damage and inflammation. Using a mouse
model of hookworm infection with Nippostrongylus brasiliensis (Nb), we identify Resistin-like
molecule (RELM)a as a highly secreted protein that protects the host from potentially fatal
infection-induced lung tissue damage at the expense of optimal hookworm killing. Our central
hypothesis is that RELMa is a host disease tolerance mechanism that shifts the balance from
helminth killing to resolution of inflammation and tissue healing. RELMa is expressed by immune
cells such as macrophages and non-immune cells such as epithelial cells (EC). In preliminary
data utilizing bone marrow chimeras and macrophage co-cultures, we identified that RELMa-
expressing alternatively activated macrophages (AAMac) are less efficient at Nb killing, but
instead dampen lung inflammation and promote tissue repair. Further, we generate unique
Arginase1/RELMa AAMac dual reporters, that reveal AAMac heterogeneity and implicate
RELMa+ AAMacs as a new wound healing macrophage subset. Based on these findings, the
focus of this proposal is to combine novel cell-specific RELMa KO/reporter mice with functional
co-culture assays and new RELMa reagents to delineate RELMa function in macrophage-
helminth interactions and mucosal tissue healing. In Aim 1, we will employ cell-specific RELMa
KO/reporter mice and adoptive cell transfers to delineate the contribution of RELMa derived from
innate cells (AAMac or eosinophils) or EC to Nb immunity and tissue healing. In Aim 2, we will
investigate RELMa regulation of macrophage-Nb interaction using AAMac dual reporter mice,
RELMa fusion proteins and blocking antibodies, and optimized co-culture assays. In Aim 3, we
will employ 3D lung scaffold and EC air-liquid interface co-cultures with AAMacs and
mesenchymal stem cells to determine how RELMa-expressing AAMacs and ECs interact with the
lung stroma and aid lung tissue recovery. We anticipate that a better understanding of the
beneficial versus pathogenic effects of RELMa in helminth infection could guide therapeutic
strategies to enhance anti-helminth immunity while limiting pathologic inflammation and
promoting tissue healing. Our findings provide new insight into alternatively activated macrophage
biology and macrophage-stromal cell interactions, which could be broadly applicable to resolving
mucosal tissue injury and inflammation that are of significant public health concern.

Public health relevance
The optimal host response to mucosal infection relies on the critical balance between pathogen killing (immunity) and limiting immunopathology (tolerance) in the host. Host disease tolerance is especially important in infections with macroparasites such as helminths that cause significant tissue damage, therefore investigating these host disease tolerance mechanisms may be applicable to the treatment of tissue injury and inflammation of significant public health impact. This proposal will investigate how the secreted protein RELMa contributes to host disease tolerance to helminths through regulation of alternatively activated macrophage subsets, macrophage-helminth interactions and macrophage-lung stromal cell interactions.